American Society for Neural Therapy and Repair Annual Conference April 2025

ABSTRACT
This R13 application seeks funding for our annual American Society for Neural Therapy and Repair
(ASNTR) meeting to support: i) travel awards for undergraduate and graduate students, medical students
and postdoctoral fellows to attend the gathering in Clearwater, FL on April 24-26, 2025, and ii) a
Workshop held onsite at the start of the meeting for all trainees and interested parties. The Society’s
Education and Training Committee, currently chaired by Dr. Agnes Luo, was established to promote the
participation and development of our trainees within the Society. To accomplish this goal, each year the
Committee encourages students and postdocs to submit their abstracts for a competitive travel award. These
abstracts are reviewed by the Education and Training Committee which gives scores based on criteria that
include: 1) Creativity of scientific approach; 2) Selection of outcome measures with emphasis on rigor and
reproducibility; 3) Quality of writing; and 4) Potential impact on the field. The top-rated students and postdoctoral
fellows are awarded travel funds to defray the cost of attending the meeting. Additionally, the top students and
post-doctoral winners are invited to give oral presentations at the conference. All trainees receiving travel awards
are required to attend the Workshop. A “Meet and Greet” session follows the Workshop, where attendees are
introduced to all attending scientists. We hope this additional, personal interaction provides an opportunity for
trainees to establish a relationship that will continue throughout their scientific career. We also plan for a
dedicated session of presentations by the top travel award winners, and a data blitz for all trainees, giving
everyone the opportunity to give a (brief) oral presentation in a relaxed environment

Public health relevance
NARRATIVE This application seeks funding to support a Trainee-Focused research day at the upcoming 32nd annual meeting of the American Society for Neural Therapy and Repair, and to support travel for pre- and post-doctoral scholars to attend the meeting. This meeting will promote introductions and ongoing interactions between young and senior scientists in academia and industry, as well as clinical professionals, to jointly discover and develop new treatments for neurological disorders. This interactive approach between basic scientists and clinicians cultivates an invigorating atmosphere of translational learning, research and career development across all career stages.